Administrative Core

Abstract
In congruence with the mission of the NIMHD funded RCMI program, the Morehouse School of
Medicine (MSM) has continued to address health equity. In alignment with the MSM Strategic
Plan, the Administrative Core (Admin. Core) will develop and strengthen the research
infrastructure necessary to achieve this goal. The Admin. Core will continue to provide
coordination and logistical support for four Cores [Research Infrastructure Core (RIC),
Investigator Development Core (IDC), Community Engagement Core (CEC) and a Recruitment
Core], plus 3 research projects. It will also continue to support health equity related research,
intellectual activities (e.g., lectures and seminars), workshops and research retreats, while
continually broadening our community partnerships across Georgia through the initial fostering
of multidisciplinary translational teams (MDTT). This describes addressing all sides of health
disparities in a team-based structure ultimately leading to health equity. We will leverage the
U54 resources at hand, other MSM resources into rural communities to expand our program
impact into the rural communities using our MDTT concept of coordinated basic, clinical, and
community research. And we will develop structures so that other researchers can access this
platform bringing to bear all aspects of MSM’s capability on those communities. Thus, in this
cycle the U54 Admin. Core will be redesigned to provide oversight, coordination, support, and
logistics for the various cores to expand the CTRHD ability to emphasize cutting edge
translational research through MDTT’s in both our current urban communities as well as
expanding our reach into rural communities. This will be accomplished through further linking
MSM’s basic, clinical, and community researchers and research, and enhancing our ability to
build the next generation of health disparities researchers. The CTRHD will achieve the above
through the following aims and specific objectives: SA1: Support administrative and logistical
support to all CTRHD cores, projects, and oversight for all CTRHD activities and partnerships;
SA2: Supervise and evaluate the impact of the CTRHD and its cores for enhancing MSM’s
mission of health equity research; increasing productivity of investigators; and MSM’s overall
success in obtaining extramural research funding. SA3: Coordinate with the RCMI Coordinating
Center with other RCMI institutions, NIH/NIMHD and other NIH funded centers and programs
across Georgia (i.e., GaCTSA).